Identification and biological effects of microbiome-derived sulfated metabolites

Project Summary/Abstract
Recent studies have shown that metabolites produced by human gut bacteria causally influence health and
disease. At the same time, the development of modern metabolomic techniques has enabled the investigation
of underexplored classes of metabolites. Here, we focus on one such class of underappreciated microbiome-
dependent molecules, the sulfated metabolome. While sulfated metabolites were long considered waste
products, new studies have revealed that they can have a variety of important physiological roles, including
effects on immune response, host metabolism, and neurological function. In addition, recent studies have
revealed that these compounds are not only host-produced – commensal bacteria have been identified that
either chemically modify or synthesize a variety of sulfated compounds. Indeed, work from our groups showed
that abundant human gut bacteria sulfonate steroidal compounds found in the gut lumen, including cholesterol.
We identified the bacterial gene responsible for this activity, and we showed that the presence of this gene
inhibited the migration of T cells in vivo. These results suggest that microbiome-dependent sulfated metabolites
affect immune function.
In this research, we propose to use analytical chemistry pipelines that we have developed to identify microbiome-
dependent sulfated metabolites, and we propose to use in vitro and in vivo studies to elucidate the immunological
effects of sulfated compounds. First, we will use bioinformatic approaches to identity putative sulfotransferases
(SULTs), enzymes that produce sulfated metabolites, in human gut bacteria. Using a comparative metabolomics
workflow that we have developed that tracks the incorporation of labeled sulfur, we will further identify sulfated
metabolites produced by SULT-containing gut bacteria, identify the responsible bacteria, and characterize the
genes responsible for sulfated metabolite biosynthesis using both biochemical and genetic approaches. Second,
we will investigate the effects of sulfated bacterial metabolites on T cell development, function, and trafficking in
vitro and in vivo. Third, we will perform feeding studies in mice and ex vivo culturing experiments in human feces
using labeled sulfate followed by comparative metabolomics in order to identify microbiome-dependent sulfated
metabolites. We will also use microbial culturing workflows to isolate gut bacteria that produce sulfated
metabolites.
This work will broaden our understanding of the sulfated metabolome. By identifying microbiome-dependent
sulfated metabolites, the genes responsible for their production, and the biological activities of these compounds,
this research will lay the groundwork for the development of new small molecule and probiotic therapies to treat
human disease, including inflammatory and autoimmune diseases.

Public health relevance
Project Narrative The sulfated metabolome – the collection of sulfate-containing small molecule metabolites – is an underappreciated source of unique, biologically active natural products. In the proposed research, we will use both hypothesis-driven and unbiased in vitro and in vivo approaches to identify microbiome-dependent sulfated metabolites as well as the biological effects of these compounds, particularly on host immune functions. Through the discovery of bioactive sulfated metabolites as well as the bacteria and bacterial genes responsible for their production, this research will lay the groundwork for new small molecule and probiotic therapies to improve host health and treat inflammatory and autoimmune diseases.